RENAL SODIUM HANDLING DURING ACUTE VOLUME EXPANSION

The goal of this protocol is to explore the determinants of shifts in adrenal and renal vascular responsiveness to AII. We studied the time course of enhanced adrenal responsiveness following a shift from a high to a low sodium intake. As another approach we compared the effectiveness of acute plasma volume expansion with saline or with a plasma volume expander, dextran, in reducing plasma renin activity and aldosterone concentration, increasing blood flow and inducing a natriuresis.